Administrative Core

ADMINISTRATIVE CORE
SUMMARY
This International Center of Excellence for Malaria Research (ICEMR) endeavors to achieve a better
understanding of malaria epidemiology, vector biology, and insecticide and drug resistance in Cameroon, a
high malaria burden country in central Africa, to inform and guide optimal malaria interventions. This program
has established a research framework with investigators from multiple institutions in the U.S. and Cameroon to
collaboratively conduct multidisciplinary malaria research across study sites in Cameroon with drastically
different ecologies and malaria epidemiology. To meet this challenge, this administrative core is established to
1) provide administrative support for managing, coordinating, and supervising the research activities of this
program to ensure that each project achieves its scientific goals; 2) provide an organizational management
plan for financial and regulatory oversight; 3) support linkages with the funding agency, scientific advisory
group, other ICEMR programs, and outreach activities; and 4) provide administrative support for the training
components of this program. We have developed an administrative structure and procedures for managing and
coordinating all research and training activities. This administrative core will facilitate research-related activities
of the program, assist in the organization of ICEMR-related meetings, and develop and submit annual progress
and financial reports. Through streamlined administration of the ICEMR, we aim to build a strong collaborative
malaria research network to successfully achieve the scientific goals of the program.